NRSA Training Core

The goal of the OSU TL1 Training Program is to educate an elite group of predoctoral and postdoctoral fellows
in translational sciences using interdisciplinary approaches associated with the movement of basic scientific
discoveries derived from and returned to the clinic. It will develop a biomedical workforce in translational
research using a curriculum aligned to core competencies, to support trainees and scholars, and to provide
guidance in career development. As a single campus university with a College of Medicine integrated within
the larger university community, we have the opportunity to train researchers across a spectrum of biological
sciences, including trainees with clinical degrees other than only the MD, including those with, or in training to
receive, a DO, DVM, PsyD or PharmD, and PhDs in the biomedical sciences, nursing, nutrition, public health,
and other health-related areas. The TL1 curriculum will explore mechanisms of human disease, develop and
improve current therapeutic approaches, and integrate basic and clinical sciences to make exciting new
discoveries that impact human health. Trainees will be provided with options for interdisciplinary curricula that
maintain high standards of intellectual rigor, foster creativity and passion for research, emphasize innovation,
and provide research opportunities with faculty who focus in the translational sciences. Special emphasis will
be placed on creating alignment of research with community engagement and outreach, as well as on
entrepreneurship and commercial partnerships. Our Program will impart interdisciplinary translational
knowledge and research skills to enable our trainees to embrace our clinical and translational research mission
and position themselves as leaders in careers translating basic science discoveries to the clinic, the community
and the commercial workplace. It provides exclusive scholarly career development and social activities for a
geographically and ethnically diverse trainee cohort to strengthen their ability to become tomorrow’s leaders in
translational research.